Unlocking Equity: Validating Methodologies & Evaluating Surgical Care for Incarcerated Individuals

PROJECT SUMMARY/ABSTRACT
Over the past 25 years, the United States (US) has witnessed a fourfold increase in its prison and jail
population, with nearly 70-90% coming from minority and lower socioeconomic backgrounds. To illustrate, one
out of every three Black males and one out of every six Hispanic males born in 2001 are projected to experience
incarceration during their lifetimes, in stark contrast to just one out of seventeen White males. There is a glaring
lack of data on their surgical care, and what is known is deeply troubling. This study, titled 'Unlocking Equity:
Validating Methodologies and Evaluating Surgical Care for Incarcerated Individuals,' seeks to deepen our
understanding of the healthcare of incarcerated individuals and ultimately impact the existing disparities in
mortality and timely surgical care.
Inmates possess the unique constitutional right to healthcare, yet the extent, quality, and outcomes after
surgery are unknown. The reasons for this knowledge gap are complex, none the least of which is the difficulty
of identifying these patients in healthcare databases. Identifying incarcerated individuals in healthcare
databases relies on the International Classification of Diseases 10th edition codes, Z65.1 ("imprisonment and
other incarceration") and Y92.14x ("prison as the place of occurrence of the external cause") or the Agency for
Healthcare Research and Quality admission source code. These codes are used ubiquitously in healthcare
databases, but their validity is unestablished. To address these critical gaps in the surgical care of incarcerated
individuals, our study has two aims. In Aim 1, we will validate methods for identifying incarcerated patients in
electronic medical records (EMR) and claims databases. The accuracy of these codes is crucial for gaining
insights into healthcare delivery for incarcerated individuals requiring surgery and in-hospital medical care. In
Aim 2, we will evaluate the timeliness of surgical care and outcomes (morbidity, mortality) of incarcerated patients
in New York State undergoing inpatient surgery using validated codes.
This study examines the public health of incarcerated individuals, a group that predominantly comes from
underserved and disadvantaged communities. It introduces an innovative method for identifying incarcerated
patients in healthcare databases, serving as an invaluable model for future research. Our multidisciplinary
investigator team and Expert Advisory Panel have expertise in the healthcare of incarcerated individuals, health
outcomes, surgical care, disparities, and policy evaluations which ensures the validity of the study. In essence,
this research addresses pressing issues in incarcerated healthcare and provides a methodological framework to
inform future studies, facilitating informed policy decisions and improved healthcare practices for an underserved
community.

Public health relevance
PROJECT NARRATIVE The United States has one of the highest incarceration rates and releases over 7 million individuals from jails and prisons annually. This project aims to develop a robust methodology for identifying incarcerated individuals within large healthcare databases, enabling a comprehensive examination of their surgical care. Despite their constitutional right to healthcare, minimal data on the disparities in the surgical care of incarcerated individuals is available, and ultimately, this endeavor holds the potential to catalyze broader healthcare improvements, reducing illness and disability within this marginalized community.